Trapping and reconstituting early stages of eukaryotic ribosome assembly

Project Summary Ribosome assembly is an essential process in all domains of life. In eukaryotes, in excess of 200 non- ribosomal factors are involved in this poorly understood process. Defects in human ribosome assembly are associated with ribosomopathies, a set of diseases, which result in high incidences of cancer. Our understanding of eukaryotic ribosome assembly is currently limited by an inability to stop this process at particular stages. We have recently developed a new technique to study early events of eukaryotic ribosome assembly as a function of transcription. This technique can recapitulate and arrest early eukaryotic ribosome assembly intermediates, thereby facilitating the analysis of eukaryotic ribosome biogenesis at an unprecedented level. In conjunction with other synergistic genetic, biochemical and structural biology methods, this technique will be used to elucidate hallmarks of early eukaryotic ribosome assembly, which previously represented intractable problems. Insights obtained from these studies will not only set new paradigms for eukaryotic ribosome assembly, but also have the potential to further our understanding of this process for the development of treatments.

Public health relevance
Project narrative In all domains of life ribosomes are assembled to produce proteins. These key molecular machines are not only vital for proteostasis but defects in their assembly have been increasingly associated with cancers and severe human diseases, commonly referred to as ribosomopathies. This proposal aims at using a new technique to elucidate the hallmarks of early eukaryotic ribosome assembly, thereby providing a foundation for the development of treatments for ribosomopathies.